HABS-HD - Core E - Disparities & Outreach Core

HABS-HD DISPARITIES & OUTREACH CORE (CORE E) - ABSTRACT
One of the primary goals of the National Alzheimer’s Project Act (NAPA) is to “improve outcomes for ethnic
and racial minority populations.” However, substantial gaps in understanding the reasons for the disparate
increase in Alzheimer’s disease (AD) and AD related disorders (ADRDs) in ethnic and racial minority
populations exist, primarily due to the underrepresentation of minority groups in aging research. Community
engagement and outreach is considered one of the most successful strategies to recruiting diverse populations
into research. The Dallas Forth-Worth (DFW) metroplex, home to the Health and Aging Brain Study-Health
Disparities (HABS-HD), is currently reflective of the future U.S. racial/ethnic population and an ideal location
to simultaneously study cognitive aging among African Americans (AA), Mexican Americans (MA; 63% of the
U.S. Hispanic population) and non-Hispanic whites (NHW). HABS-HD is the first large-scale, community-based
project to simultaneously study each of the AT(N) defined biomarkers, in alignment with the NIA Health
Disparities Research Framework. The long-term goal of HABS-HD is to establish population-specific informed
precision medicine for novel treatment and prevention strategies as called for in NIA AD+ADRD Research
Implementation Milestone 1. For nearly 10 years, HABS-HD has built a network of community ties and
relationships using a community-based approach to recruitment. This approach, which emphasized outreach,
engagement, and collaboration between the research team and key stakeholders in the community, led to the
successful recruitment of 2,000 participants (n=1,000 NHW, 1,000 MA) aged 50 and older and longitudinal
follow-ups are underway. Based on UNTHSC Institutional funding, the cohort has expanded to include 1,000
AAs with recruitment to be completed prior to initiation of this U19. As part of the proposed U19, the primary
goal of the Core E is to further increase awareness and engagement of diverse communities into research and
to provide the outreach infrastructure to comprehensively understand the development and progression of AD
and ADRDs across the lifecourse. To address this goal, Core E will address the following Specific Aims: Aim
1: Extend the recruitment of the HABS-HD cohort to ages 30-49 (n=500 per racial/ethnic group), retain existing
participants, and recruit new participants to counteract attrition. Aim 2: Generate and disseminate educational
materials regarding the importance of brain aging over the lifecourse and the importance of research in diverse
communities. Aim 3: In collaboration with all Cores and Projects, continue to monitor and ensure that all
HABS-HD activities are conducted in alignment with the NIA Health Disparities Research Framework.